Immunology (I) Core

Project Summary (Immunology)
Continuing funds are requested by 17 vision scientists (holding 13 eligible NEI R01 grants) and
their personnel to support three resource/service cores and an administrative core in the newly
merged Department of Ophthalmology, Visual and Anatomical Sciences (former Ophthalmology
and Anatomy/Cell Biology Departments). The Immunology (I-Core) will be directed by Dr. Ashok
Kumar, an R01-funded investigator with significant expertise in immunological techniques.
Together with the PI, and a research assistant, the environment and capability to conduct vision
research at Wayne State University and affiliated institutions will be enhanced through
prioritization of the work of NEI R01 funded investigators, their staff and students (graduate and
fellows) in numerous aspects of Immunology. This core will ensure vision researchers have
ongoing access to contemporary instrumentation and approaches in flow cytometry/FACS and
other immunological assays to facilitate their research. The I-core maintains flow cytometry,
western blotting, ELISA, and other capabilities that enable advanced cell analyses for a wide
range of research areas. The experimentation supported by I-core will continue to provide
sophisticated immunological assays and expert consultation/training to the vision research
community, maximize and centralize specialized immunology research tools, and initiate and
stimulate innovative research projects addressing emerging questions of eye diseases. Priority
for NEI R01 funded investigators at Wayne State University (WSU) and other affiliated
institutions will be provided. The I-core also provide a supportive environment to foster
collaboration among NEI R01 funded investigators, clinicians, and other WSU and affiliated
investigators to develop and carry out basic and translational vision research. The I-core also
will provide support, at reduced priority, for new investigators, and/or others who are collecting
preliminary data to be used for NEI R01 grant submission.